Cognitive progression among older adults with subjective cognitive decline and mild cognitive impairment: the roles of sleep and physical frailty

PROJECT SUMMARY
Individuals with Subjective Cognitive Decline (SCD) and mild cognitive impairment (MCI) are significantly more
likely to have increased AD biomarkers (e.g. amyloid β) and higher risks of developing Alzheimer’s Disease
and Related Dementias (ADRD). Sleep disturbances have been associated with increased risks preclinical AD,
ADRD, and all-cause dementia. However, most of these studies focus on sleep’s association with the
incidence of SCD, MCI, or dementia individually, rather than the progression of cognitive impairment from SCD
to MCI to dementia. The latter is of key clinical importance when attempting to halt or treat AD progression. In
addition to sleep, recent studies have shown that physical frailty is also closely interrelated with cognitive
impairment, with evidence that they predict one another, share common risk factors, and have similar potential
mechanisms. The co-existence of both physical frailty and cognitive impairment (MCI/SCD), also known as
cognitive frailty, is supposed to be a predictor of severe health consequences with the synergic negative
effects of both. However, this synergic effect on future cognitive decline and progression to dementia is still
underexamined in the literature. Moreover, given the interrelationship between physical frailty and cognitive
impairment, it is possible that physical frailty moderates the associations between sleep disturbances and
progression from SCD/MCI to dementia. Therefore, the overall goal of this project is to investigate the roles of
sleep disturbances and physical frailty in SCD/MCI’s cognitive progression and explore whether physical frailty
is a moderator of sleep’s association with the cognitive progression. In the F99 phase, the PI will use six waves
of longitudinal Health and Retirement Study data from the 2010 to 2020 to examine the associations of
baseline self-reported insomnia symptoms and physical frailty with 10-year cognitive trajectories and
subsequent incidence of MCI/dementia in SCD. In the K00 phase, the PI will shift the population to MCI, a
more advanced AD stage, with a focus on actigraphy-measured sleep and neuroimaging cognition measures.
The PI will use the UK Biobank data to examine the associations of sleep (both actigraphy-derived and self-
reported) and physical frailty with brain structure (magnetic resonance imaging data), subsequent cognitive
function, and incident ADRD among older adults with MCI. In both phases, physical frailty will be examined as
a moderator in the associations between sleep and cognitive outcomes. This research will help to pinpoint at-
risk populations for ADRD, advance understanding of the roles of sleep and physical frailty in ADRD
progression in SCD and MCI, and suggest strategies for delaying AD/dementia progression through the lens of
sleep and physical frailty. Further, the training objectives nested in the F99 and K00 phases of this award will
allow the PI to gain necessary knowledges and skills to develop into an independent investigator in aging
research, with a focus on the sleep and cognitive health in older adults.

Public health relevance
PROJECT NARRATIVE This project investigates the impact of sleep disturbances and physical frailty on the cognitive progression of older adults with subjective cognitive decline (SCD) and mild cognitive impairment (MCI), as well as the moderating effect of physical frailty on the relationship between sleep disturbances and cognitive outcomes. By exploring these factors, the study aims to shed light on the mechanisms underlying the conversion from SCD/MCI to Alzheimer’s Disease and Related Dementias (ADRD). The findings will help to identify vulnerable populations and proposing public health strategies for delaying or preventing ADRD progression in SCD and MCI cohorts, with a focus on sleep and physical frailty.